INHALED HUMAN INSULIN WITH SUBCUTANEOUS HUMAN INSULIN IN IDDM AND NIDDM

Patients are doing well with this new delivery system "inhaled insulin". No adverse events, great compliance and good glucose control.